Viral vectors for desensitization-resistant nAChRs

PROJECT SUMMARY
Tobacco dependence represents a major public health challenge, and novel treatment approaches are urgently
needed. Nicotinic acetylcholine receptors (nAChRs) are known to mediate the addictive action of nicotine, but it
has been difficult to know which aspects of nAChR function are involved in the behavioral and physiological
response to nicotine. In particular, the contribution of nAChR activation vs. desensitization to the establishment
and maintenance of nicotine reinforcement has remained unclear. We will leverage our unique experience with
nAChR molecular pharmacology and self-administration assays to address this issue. In Aim 1, we will design,
produce, and validate AAV vectors for expression of desensitization-resistant β2 and β4 nAChR subunits. We
will test several β2 and β4 variants with specific mutations at a conserved leucine residue in the 2nd
transmembrane ⍺-helix (i.e. the “pore-forming” ⍺-helix). Patch clamp electrophysiology will be used to
characterize the biophysical change induced by the mutation, and 2-photon laser scanning microscopy and
nicotine uncaging will verify proper trafficking of variant subunits in neurons. In Aim 2, we will study how
removal of β2 desensitization in VTA impacts nicotine self-administration and dopamine release. We will test
the hypothesis that a lack of desensitization will fundamentally alter nicotine's action as a reinforcer. We will
also determine how removal of desensitization from VTA β2* nAChRs impacts evoked dopamine release using
electrochemical methods. Together, these Aims will 1) produce/validate novel tools for nAChR research and 2)
help us understand how nAChR desensitization normally modulates nicotine reinforcement and associated DA
release. These vectors and their characterization in behavioral assays will lay the groundwork for future projects
related to nAChR physiology and pharmacology, and may also facilitate the development of novel tobacco
cessation treatments.

Public health relevance
PROJECT NARRATIVE Nicotine/tobacco dependence is a major health concern, and mechanistic neurobiological research into addiction mechanisms may lead to novel approaches to tobacco cessation. The goal of this project is to leverage our well- qualified research team, our innovative tools, and our incisive methods to produce newer/better tools for studying nicotinic acetylcholine receptor activity in the context of nicotine dependence. We will then validate and leverage these tools to investigate novel aspects of nicotine dependence.